Colorado Clinician Scientist Training Program

Abstract
Advancing patient care in otolaryngology is critically dependent on training future leaders in the field to
become successful independent researchers and drive advancements in patient care. Most otolaryngology
residency programs offer limited research training and there is a dire need for well-trained
independent physician investigators in the specialty. New approaches are required to recruit budding
physician investigators into academic research-focused careers in Otolaryngology. Therefore the goal of
this new R25 application is to provide exceptional research training in otolaryngology-related research to
carefully selected medical students and Otolaryngology residents. Trainees will receive research training and
career development to set them up with the skills required to become outstanding clinician scientists
able to perform high impact research. Resident trainees will undergo 18 months of research integrated
into their 6 year residency training program. Research training for medical students will occur in the third
year of medical school with a dedicated 9 month research block.
One resident and one medical student with exceptional research promise and dedication to an
academic career in Otolaryngology will be selected from diverse applicant pools and admitted each
year into the research training program. The Department of Otolaryngology has a balanced, well-funded
and expanding research portfolio and an excellent track record of producing physician scientists through
our existing NIDCD T32 training grant. Funded faculty with active research programs will serve as research
mentors and clinically-focused faculty will serve as career mentors. The wider community at The University
of Colorado Anschutz Medical Campus has major strengths in all areas related to Otolaryngology including
hearing, balance, smell, taste, speech, language and disorders of communication and head and neck
cancer. The research training faculty has existing extensive research collaborations which will continue to
grow and foster an outstanding team-based training environment and unique training experience for
each of our trainees. The intensive research and mentoring program for each trainee will involve
individualized development plans, training in innovative research methods, structured didactics and rigorous
ethics education.

Public health relevance
Narrative The goal of this application is to train outstanding physician scientists in otolaryngology who will contribute to cutting edge science in the field and drive advancements in patient care. Support is requested for in- depth research training and mentoring for residents and medical students.